Mesenchymal Regulation of Osteogenesis

PROJECT SUMMARY
To devise novel treatments for craniofacial birth defects, disease, and injuries, more research is needed to
understand developmental mechanisms that control jaw length. The jaws often display a range of size-related
anomalies including mandibular hypoplasia, retrognathia, asymmetry, and clefting. Our study will provide critical
data to address this unmet need by focusing on how jaw length is regulated during the deposition and resorption
of bone. We employ a unique quail-duck chimeric system that we created for manipulating neural crest
mesenchyme (NCM), which are the precursor cells that form the jaw skeleton. Quail have much shorter jaws
than do duck. Transplanting NCM between quail and duck embryos generates chimeras with the jaw length of
the donor species, but the molecular and cellular mechanisms through which NCM accomplishes this complex
task remain largely unknown. In our published and preliminary studies, we uncover a direct correlation between
jaw length and the NCM-mediated expression of ligands, receptors, and effectors of the Transforming Growth
Factor-Beta (Tgfβ) pathway, which is known to promote bone deposition and resorption. We observe that Tgfβ
receptor 1 (Tgfβr1), and targets including an osteogenic factor (Runx2) as well as a bone-resorbing collagenase
(Mmp13) are highly upregulated in quail compared to duck. If we over-express Runx2 or Mmp13, we shorten the
jaw whereas inhibiting Mmp13 lengthens the jaw. We also find species-specific variation in Runx2 isoforms and
in the promoters of Tgfβr1 and Mmp13. Thus, we hypothesize that multiple hierarchical levels of gene regulation
in the TgfFβ pathway generate species-specific differences in sensitivity to TGFβ signaling, modulate bone
deposition and resorption, and enable NCM to control jaw length. To test our hypothesis, we propose three
complementary Specific Aims. In Aim 1, we will determine the extent to which NCM utilizes differential expression
of Tgfβr1 to control Tgfβ pathway activation, bone deposition and resorption, and jaw length. We will identify
species-specific regulatory elements and assay for cell-autonomous versus context-dependent mechanisms that
affect Tgfβr1 expression. In Aim 2, we will determine the extent to which NCM deploys combinatorial, spatial,
temporal, and/or species-specific expression of Runx2 isoforms to regulate targets, bone deposition and
resorption, and jaw length. We will identify developmental contexts in which Runx2 is alternatively spliced and
use gain- and loss-of-function approaches to interrogate the ability of Runx2 isoforms to control bone growth. In
Aim 3, we will determine the extent to which NCM leverages species-specific differences in Mmp13 regulation
to modulate jaw length. We will manipulate upstream transcriptional inputs and endogenous promoter elements
of Mmp13 and use gain- and loss-of-function strategies to test if regulatory changes to Mmp13 provide spatial
and temporal control over local resorption and growth of bone. Each Specific Aim is clinically relevant in providing
data on critical stages and mechanisms that could be targeted via novel molecular therapies to benefit patients
with jaw length defects. Currently invasive surgery and/or orthodontics are the only treatment options.

Public health relevance
PROJECT NARRATIVE What determines the length of the jaw skeleton? Answering this question is important for preventing and treating birth defects, as well as for devising new therapies to repair or regenerate bones affected by injury or disease. The overall goal of this project is to identify molecular and cellular mechanisms that control jaw length.